Reduction of Brain AVM Severity through Inhibition of Pathogenic Angiogenesis

Abstract
Vessels in the nidus of brain arteriovenous malformation (bAVM) have abnormal wall structure and
are prone to rupture, causing life-threatening intracranial hemorrhage and long-term disability. Brain
AVM rupture is often unpredictable. There is no specific therapy for preventing it.
An abnormally high level of vascular endothelial growth factor (VEGF) has been implicated in bAVM
pathophysiology. Studies show that interruption of VEGF signaling prevents bAVM progression. Anti-
VEGF antibodies and tyrosine kinase inhibitors (TKIs) have been used to block VEGF signaling in
many settings. However, both antibodies and TKIs cause adverse effects in patients. Since bAVMs
are chronic and active angiogenic lesions, long-term VEGF inhibition will be needed to inhibit bAVM
progression and stabilize AVM vessels. Antibodies and TKIs need repeated dosing, which is costly
and inconvenient. In addition, recent studies show that TKIs have no effect on mouse skin AVMs, and
genetic deletion of the angiogenic signal-transducing VEGF receptor-2 (VEGFR-2) prevents
excessive angiogenesis but does not fully revert AVM formation. These data suggest that blocking
VEGF angiogenic effect is insufficient to treat AVM in certain tissues. A better reagent is needed to
prevent bAVM development and rupture.
Soluble FMS-related tyrosine kinase 1 (sFLT1) containing extracellular domain of VEGFR-1 binds
VEGF with high affinity, and thus reduces VEGF signaling through its membrane-bound receptors.
More importantly, sFLT1 has a direct role in maintaining normal pericyte function. We have tested a
sFLT1 gene therapy strategy in our bAVM mouse models, and have shown that intravenous delivery
of an adeno-associated viral vector expressing sFLT1 reduces bAVM severity. However, ubiquitous
expression of sFLT1 caused some adverse effects. In this study, we hope to demonstrate that sFLT1
improves bAVM vessel-integrity by inhibiting VEGF signaling and improving adhesion of pericytes to
endothelial cells (Aim 1). We will also test whether targeted sFLT1 expression reduces bAVM severity
with minimal side effects using AAV vectors that infect neurons or endothelial cells specifically in
combination with neuron specific or brain endothelial specific promoter (Aim 2), and whether
reduction of microglia/macrophage infiltration enhances sFLT1 therapeutic effect (Aim 3). We will also
investigate mechanisms by which sFLT1 therapeutic effects occur in all aims. The overarching goal of
this project is to develop a safe and effective method to prevent bAVM hemorrhage.

Public health relevance
Project Narrative Rupture of vessels in the lesion of brain arteriovenous malformations (AVMs) can cause life threatening intra- brain hemorrhage and long-term disability. Currently, there is no safe and effective medical therapy available to prevent it. This project will test a new therapeutic strategy to prevent the rupture of vessels in brain AVMs.